Using Sleep Health to Optimize Smoking Cessation Treatment Response in HIV-Positive Adults

Project Summary
Cardiovascular disease (CVD) is a major cause of morbidity and mortality in adults living with HIV (ALHIV), and
cigarette smoking is the single most important modifiable CVD risk factor in this population. Success rates for
existing smoking cessation interventions are relatively low. Poor sleep is more prevalent among smokers, more
prevalent among ALHIV, can be caused by smoking cessation attempts, predicts relapse to former smoking
patterns, and represents a parallel pathway to morbidity including increased cardiovascular disease (CVD)
among ALHIV. Thus, unhealthy sleep may make smoking cessation more difficult and increase cardiovascular
risk and other poor health conditions in ALHIV. Yet, poor sleep is amenable to nonpharmacologic interventions,
and a pilot study from our group revealed that a sleep health intervention increased smoking cessation rates
when added to routine smoking cessation treatment. The mechanisms by which improvements in sleep health
enhance tobacco cessation are unknown, but improved cognitive and affective functioning are two candidates.
To evaluate the efficacy of our sleep training approach to improve sleep health and increase smoking cessation
rates in ALHIV, the proposed study will supplement an empirically-supported smoking cessation program (6-
session, 15-week counseling program with varenicline) with a Sleep Training Approach to Reducing Smoking
(STARS) intervention developed for smokers. This intervention uniquely addresses (1) existing sleep difficulties,
if any, prior to quitting that may be associated with HIV status or nicotine use; (2) inoculation against future sleep
difficulties brought on by quitting and/or varenicline; (3) acute intervention on sleep efficiency and duration as
the participant progresses through the program; and (4) development of healthy sleep habits to carry forward
beyond the intervention. This approach is based on the gold-standard approach to treating insomnia (Cognitive
Behavioral Therapy for Insomnia) but includes a number of novel elements tailored to this population. STARS
will be compared to a General Health (GH) educational control. The study will recruit N=200 ALHIV smokers
who are interested in quitting. They will be randomized to smoking cessation with either STARS (N=100) or GH
(N=100). The study will measure the efficacy of STARS versus GH to improve objectively measured healthy
sleep metrics, assess its impact on smoking cessation as well as other metrics of CVD risk, and determine
whether cognitive and affective variables mediate the association between sleep health and smoking cessation.
Results of these studies will provide practical information as well as mechanistic insight into how sleep health
can be leveraged to optimize smoking cessation treatment in ALHIV.

Public health relevance
PROJECT NARRATIVE Smoking is a leading public health problem, especially for adults living with HIV (ALHIV), who have higher rates of smoking and more cardiovascular disease than the general population. Poor sleep is more prevalent among ALHIV, more prevalent among smokers, can be caused by smoking cessation attempts, predicts relapse to former smoking patterns, and is linked to multiple comorbidities including cardiovascular disease. This study will prospectively test a novel sleep health intervention in ALHIV smokers to determine if it improves sleep health and enhances quit rates, and whether improvements in cognition and affect mediate the relationship between sleep health and smoking cessation.